Evaluating UTT with a National HIV Cohort to Optimize South Africa's HIV Response (ENCORE)

Project Summary
Universal Test-and-Treat (UTT) could end the HIV epidemic if enough people start and stay on treatment. In
2016, South Africa eliminated CD4 eligibility criteria for antiretroviral therapy (ART) and, in 2017, the country
moved to start patients on the same day as diagnosis. These policies were designed to increase ART
coverage and have been shown to be effective in clinical trials. However, the real-world effectiveness of these
UTT policies at scale is not known. Understanding the impact of UTT and at what stages of the UTT cascade
patients are lost will be critical to guide the next phase of South Africa’s HIV response.
In collaboration with the National Health Laboratory Service (NHLS), we previously developed a National HIV
Cohort by de-duplicating the complete laboratory records of South Africa’s public sector HIV program (>12
million patients at >4000 facilities since 2004). The unique patient identifier that we created and validated
enables longitudinal follow-up of all patients nationally from clinical presentation to viral suppression regardless
of where they seek care. The cohort is unique in its ability to follow patients who transfer to other facilities
without informing their prior clinic. However, it is limited in its ability to assess events that do not include a
laboratory test, such as medication pickups.
For this proposal, we will update the NHLS National HIV Cohort through the UTT era and link it with data from
South Africa’s facility-based ART monitoring and evaluation system. We will use this integrated cohort to
quantify losses at each stage of the UTT cascade and to assess systemwide retention and transfer in the UTT
era. We will then evaluate the impact of two UTT policies – eliminating CD4 criteria and implementing same-
day ART – on time from clinical presentation to ART uptake, retention, and viral suppression.
South Africa has the largest HIV treatment program in the world. Yet until recently, just half of HIV-infected
people in South Africa were virally-suppressed. UTT was South Africa’s largest HIV policy shift since the initial
ART rollout in 2004. Our study is innovative because it offers a unique national, longitudinal view of the HIV
care cascade in South Africa. Our study is significant because we will determine the extent to which UTT has
increased ART coverage and viral suppression and we will identify where in the UTT cascade patients leave
care, illuminating opportunities for intervention.

Public health relevance
Project Narrative Universal Test-and-Treat (UTT) represents the world’s best chance to end the HIV epidemic; yet research on UTT impact in South Africa is limited. We constructed a National HIV Cohort from the complete laboratory records of South Africa’s HIV treatment program, covering over 4000 facilities. Integrating this cohort with treatment monitoring data, we will evaluate the national impact of UTT and identify where in the UTT care cascade patients are lost to follow-up, in order to guide the next phase of South Africa’s HIV response.